Regulation of the Dachs core complex in tissue growth control

Project Summary/Abstract
Proper coordination of tissue growth is of fundamental importance both in normal development and in
many disease processes, including cancer. Studies in Drosophila and mammalian systems over the
past 20 years or so have identified the Hippo pathway as a central regulator of tissue growth. As with
many signaling pathways, Hippo components include transmembrane proteins, a cytoplasmic kinase
cascade, and output mediated through nuclear transcription factors. However, regulation of Hippo
signaling is unusually complex, involving mechanical tension, apical-basal polarity, feedback loops, and
regulated assembly of different pathway components at spatially distinct regions of the cell cortex. In
addition, further pathway control is exerted by components of the planar cell polarity mechanism,
specifically by output from Fat/Dachsous signaling. Fat and Dachsous are both large transmembrane
protocadherins that function to control the abundance and localization of an atypical myosin named
Dachs. Dachs does not appear be a functional motor protein, but instead functions at the cell cortex to
regulate pathway activity at the level of the kinase cascade. Studying the Hippo pathway, and in
particular Fat/Dachsous signaling, offers an extraordinary opportunity to learn how multiple inputs that
are sensing distinct environmental cues are coordinated to control the output of an important
developmental and disease-related growth control pathway.
In this proposal, we describe experiments designed to unravel some of the complexity underlying Fat-
Dachsous signaling so that we can elucidate the underlying molecular principles essential for its
function. First, we propose the notion of a 'core complex' of proteins that interact with and recruit Dachs
to the cell cortex where it functions to promote growth. In the absence of upstream regulation, these
proteins are maximally active. We describe experiments designed to better understand how this
complex forms and what factors regulate its ability to assemble at the cell cortex. Second, we propose
the notion that Fat and Dachsous together function to repress activity of the core complex, and thereby
control tissue growth. Based on previously published data and our own unpublished observations, we
propose a previously unrecognized role for Dachsous in removing Dachs from the cell cortex via
endocytosis, and describe an experimental plan to rigorously test this hypothesis. Together, the results
of these studies have the potential to fundamentally change our mechanistic understanding of
Fat/Dachsous signaling in the Hippo tissue growth control pathway.

Public health relevance
Project Narrative Tissue growth during development and in a number of human diseases is regulated by output of the Hippo growth control pathway. Studies in Drosophila have shown that one of the mechanisms that controls Hippo pathway activity is output from Fat/Dachsous signaling mediated by an unusual myosin- like protein named Dachs. Our goal in this proposal is to use the powerful genetic, molecular and cellular tools available in Drosophila to understand how the function of Dachs and its interacting partners is regulated at the cell cortex to control tissue growth.